Fostering diversity in the next generation of HIV researchers to improve the HIV continuum of care

PROJECT SUMMARY. Significance. Great progress has been made toward the UNAIDS 95-95-95 goals
worldwide, and novel methods for HIV prevention are beginning to decrease the size of the epidemic.
However, much work on the HIV continuum of care remains. Racial and ethnic diversity among HIV
researchers will be critical in developing new approaches to address the gaps that currently elude the best HIV
science conducted to date. Yet, funding rates for underrepresented in medicine/public health (URiM)
researchers are well below those of white researchers (~15% versus 25% overall) and only 6% of K career
development award applicants have been URiM trainees. Approach. In Aim 1, the Fostering Diversity in HIV
Research Program uses Social Cognitive Career Theory and the Mentoring Across Difference framework to
train mentors in key skills to successfully support URiM trainees. Workshops are held annually with additional
quarterly sessions. In Aim 2, the program provides structured research mentorship exclusively to URiM
trainees to address the HIV continuum of care. Trainees are identified primarily through residency and post-
doctoral fellowship programs at Massachusetts General Hospital and master’s degree and PhD programs at
the Harvard T. H. Chan School of Public Health; however, individuals from other institutions are eligible.
Trainees receive formal didactics on the HIV continuum of care and career development, focusing on issues
particularly relevant for URiM trainees (e.g., implicit bias, resiliency in research). Mentors support URiM
trainees in gaining knowledge about behavioral HIV research, as well as provide the hands-on technical and
professional skills needed to develop successful research careers. All activities are tailored to the needs of
URiM trainees and each individual’s stage of training. Research addresses the following areas of the HIV
continuum of care both domestically and globally: PrEP delivery and adherence; HIV testing and outreach;
linkage, retention in care, and ART adherence; chronic care and complications of treated HIV; and maternal
health and perinatal transmission. Supplement activities will support an intensive 6-week Program in Clinical
Effectiveness to “kickstart” clinical research careers for those completing residency or transitioning from
complementary fields, in addition to the above-noted program activities. Primary outcomes of the program are
HIV research mentors with the necessary mentoring competencies to successfully support URiM trainees, as
well as high quality, satisfying, and impactful mentorship of URiM trainees who achieve core research
competencies. Other outcomes include trainee scholarship (i.e., manuscripts and grants), progression of
trainees through the academic research pipeline, and fidelity of program implementation. Innovation. This
program is innovative in its 1) targeted training of mentors to effective support URiM trainees, 2) focus on the
transition periods when many trainees leave academic research, 3) creation of a broad-based Community of
Practice among URiM trainees, and 4) interdisciplinary focus, fostering cross-collaboration and team science.

Public health relevance
Project narrative Racial and ethnic diversity is lacking among HIV researchers. Efforts to promote clinical HIV research careers among aspiring investigators from under-represented in medicine backgrounds could benefit from mechanisms for acquiring foundational skills in biostatistics and clinical epidemiology. The Kickstart Program will provide two individuals with an immersive experience to gain these skills through the Program for Clinical Effectiveness at the Harvard T. H. Chan School of Public Health as well as facilitate entry of these trainees into Fostering Diversity in HIV Research Program for ongoing mentorship, exposure to HIV research and career development training, and facilitated research experiences.